Administration

The Jackson Laboratory Cancer Center (JAXCC) is an organizational unit with dedicated administrative oversight that is strategically integrated with the parent organization's administration. Dr. Edison Liu, JAXCC Director, heads the Cancer Center administration, working with other members ofthe JAX executive committee, the Senior Management Team; Drs. Braun, (Center Deputy Director), Donahue (Director of Genetic Resource Science and co-Project Leader Cancer Models Development Resource) and Hewett (JAX Executive Vice President and Chief Operating Officer). Dr. Barbara Tennent, Associate Director for Research Administration provides dedicated administrative support to the JAXCC and reports to Dr. Liu. Two committees comprise the formal administrative structure ofthe JAXCC. The Operations Committee, chaired by Dr. Liu comprises Drs. Braun, Hewett, Nair and Tennent, and works to ensure that the overall direction ofthe JAXCC operations anticipates and supports the needs of JAXCC members. The Shared Resources Management Committee, which comprises Ms. Valerie Scott, Senior Director of Scientific Services, Ms. Yu-Hui Rogers, Site Director, JAX Genomic Medicine, and Drs. Donahue and Tennent coordinate the operations and development of CCSG-supported shared resources across campuses. Funds are requested for partial support of Dr. Tennent's administrative responsibilities. She oversees the necessary planning, policy development, budget development and research developmental activities for the ongoing growth ofthe JAXCC cancer research focus. Dr. Tennent is the primary coordinator for scientific and administrative management of the JAXCC. She is an ex officio member of the Scientific Executive Committee and serves on the Operations Executive Committee and the Shared Resources Committee. She works closely with all members ofthe administrative team to coordinate the activities ofthe JAXCC, including organization of the External Advisory Board meetings, management ofthe pilot project process, and membership records. Dr. Tennent is the primary administrative contact for NCI Cancer Center program officials and is responsible for management ofthe renewal, progress reports and requests from NCI as required. Institutional funds support dedicated effort for Ms. Scoff, who oversees the four institutional scientific services for which CCSG support is requested. She is responsible for advocacy, policy development and application, budget management, operations, quality assurance, technical staffing and development, planned technology acquisition and implementation as well as user communications. Institutional funds also support Ms. Roger's together in implementing processes, procedures and management structure that facilitate efficient resource sharing and access to CCSG-supported resources. The JAXCC is strongly supported by institutional administrative offices including the Office of Sponsored Programs for pre and post award administration, compliance, and financial management of the CCSG; Financial Services for budget development and account management; and Scientific Program Development, for securing external funding from foundations and federal agencies for research, education, and resource programs.